Novel, Non-hormonal Therapeutic for Endometriosis

PROJECT SUMMARY:
The ultimate goal of the project is to develop the first disease-modifying (“curative”) and non-hormonal
therapeutic for endometriosis. Endometriosis is considered the greatest overlooked epidemic in women’s health,
affecting approximately 10% of women worldwide. It is a major cause of infertility and disability among
adolescents and women across all ethnicities. Shockingly, to date, there is no cure for this chronic and prevalent
disease that takes 6-10 years to be diagnosed. Currently, the management of endometriosis is through hormonal
treatment, pain therapies, or surgical interventions—which fail to reverse the disease or address the root cause—
are often insufficient. Hormone pills and GnRH antagonists (causing “medical menopause”) prescribed to
patients with endometriosis can induce many undesirable side effects. Many women who undergo endometriosis
excision will have recurrence within 5 years of surgery. Hysterectomies are recommended for women who do not
experience relief through less invasive methods. NICHD has made the development of a non-hormonal
therapeutic for endometriosis a high priority goal, which corresponds with the 2021-2025 NIH-wide strategic
plan and “bold prediction” of advancing one non-hormonal therapeutic for endometriosis to clinical trials. Our
group intends to accomplish this “bold prediction” with this Phase IIB SBIR application.
Our team developed a novel therapeutic option for endometriosis by targeting a downstream component of
a pathway known to contribute to endometriosis pathogenesis, endometrial migration and invasion. We
successfully accomplished our milestones from both Phase I and II of our SBIR Fast-Track Grant. A lead
candidate was identified that has therapeutic efficacy with no observable toxicity. The lead candidate specifically
and selectively inhibits this downstream component and shows success in cell potency assays, apoptosis assays,
serum stability, membrane permeability, and vaginal absorption without irritation. In vivo, the lead candidate
importantly demonstrates endometriotic lesion regression accompanied by increased apoptosis, decreased
proliferation, and decreased downstream target genes without inducing toxicity or alterations in estrous cyclicity.
Thus, our lead candidate exhibits great potential to act as an endometriosis therapeutic to eliminate lesions.
Other molecules have regressed endometriosis progression in academic settings, but have off-target or upstream
pathway targets that make them undesirable therapeutics as undesired side effects are induced.
During Phase IIB, we will determine a minimal efficacious dose of the lead therapeutic, optimize
formulations of the lead candidate, and finish IND-enabling toxicology studies for submission of an IND package
to the FDA. By doing so, we will develop a non-hormonal therapeutic that is disease-modifying; consequently,
due to the high unmet need for endometriosis therapeutics, successful completion of our aims will allow us to
submit our application to the FDA for IND allowance and commence clinical trials. Successful completion of this
project will give women suffering from endometriosis a curative solution to eliminating the disease.

Public health relevance
PROJECT NARRATIVE: The goal of this project is to develop a therapeutic for treating endometriosis. Endometriosis is a high priority research area of NICHD. NIH has also stated as a goal in the 2021-2025 Strategic Plan that “at least one, novel, non-hormonal pharmacologic treatment for endometriosis [will be] identified and moved to clinical trials.” This is an aspirational goal because current management protocols for endometriosis—including hormones and surgery—do not address the root cause of the disease, fail to reverse disease progression, leave a chance of recurrence, and often present patients with undesirable side effects. We have identified a lead candidate that specifically targets a downstream pathway component known to contribute to endometriosis pathogenesis and endometrial migration and invasion. In this Phase IIB application, we will further develop this lead candidate for IND submission to the FDA for allowance to begin clinical trials.